A Tissue Engineering Approach to Analyzing Host-Microbe Interactions in Cancer

There remains a critical knowledge gap regarding the spatiotemporal dynamics of bacterial tissue dissemination, as well as how a diverse range of bacteria broadly and differentially influence phenotypes referred to as the hallmarks of cancer. As one particularly illustrative example, Fusobacterium nucleatum is a resident, non-motile, Gram-negative anaerobe of the oral cavity with the ability to disseminate and cause lethal infections of the brain, lungs, and liver, and is often found in abundance in colorectal cancer (CRC) tissue. It is known that entry of this bacterium into host cells is a critical component in the activation of pro- oncogenic pathways, yet the tissue dissemination mechanisms for F. nucleatum past initial cellular entry in the oral cavity remains poorly understood. Recently it was demonstrated that this bacterium is able to survive within infected host tumor cells for long enough to be carried along to distant metastatic sites such as the liver. And we have more recently demonstrated that these bacteria invade CRC organoids, and intriguingly localize to crypt niches of critical importance in CRC progression. These observations suggest a potential role for bacteria in CRC and provide a rationale to further understand how F. nucleatum gains access to normally sterile tissues. We believe that recent breakthroughs in tissue engineering will enable studies that are capable of revealing the broad-ranging effects of bacteria in the tumor microenvironment (TME), including but not limited to i) the dissemination dynamics through blood vessels and within the tumor perivascular niche, and ii) the impacts of bacteria on CRC progression via regulation of epithelial-to- mesenchymal transition (EMT) that has been implicated in the colon stem cell niche. In this highly exploratory R21 project we will overcome the major limitations to such studies, which include the over- proliferation of tumor and bacterial cells in vitro, and the limited spatiotemporal resolution in vivo. We will leverage tissue engineering combined with microfluidic analysis and bacterial genetic technologies to enable high-resolution studies of tumor-microbe interactions in an in vitro biological system modeled after the human TME. We will proceed with the following aims: 1) Develop a microfluidic spheroid-based tissue model capable of mimicking F. nucleatum tropism out of the circulation and into the colon TME, and 2) Perform unbiased transcriptome and epigenome profiling of epithelial pathway activation resulting from F. nucleatum infection under fully-defined CRC TME conditions. More broadly, this project could result in an adaptable technology with higher throughput, accuracy, and cost-effectiveness compared with competing methods to analyze dynamic host-pathogen interactions, help to define new roles for tumor-microbe interactions in complex cancer processes, and aid in the identification and screening of future targets for cancer vaccines or therapies.

Public health relevance
PROJECT NARRATIVE Bacteria exert a profound influence on human health and disease, yet there remains a critical knowledge gap in how invasive bacteria gain entry into human cells during infections of interior tissues and organs, and how these bacteria may impact tissue phenotypes and chronic diseases such as cancer even at low infection ratios. In this project we will develop a powerful analysis platform to complement existing in vitro and in vivo tools, utilizing tissue engineered microtissue arrays to characterize how the anaerobic bacterium Fusobacterium nucleatum actively invades the colon tumor perivascular niche and impacts local cell phenotypes and epigenomes under different tumor microenvironment conditions. These 3D tissue platforms are engineered using a novel fully 3D printed device that enables concurrent live confocal imaging of bacterial invasion, within a cost-effective and powerful co-culture platform that could ultimately rival animal models for studies of host- pathogen interactions in cancer and other diseases.